Defining novel drivers and predictive signatures of metastasis in osteosarcoma th

PROJECT SUMMARY/ABSTRACT The large majority of cancer-caused deaths (>90%) do not result from the primary tumor, but from the spread of cancer cells from their location of origin to other sites of the body - a process known as metastasis. Despite this understanding, most cancer treatments are designed to target the primary tumor, not metastatic lesions. A major limitation in developing targeted anti-metastatic therapies is a lack of understanding of the biological drivers of this process in cancer cells. It has been demonstrated by a number of recent studies that epigenetic marks identifying gene enhancer elements across a cell's genome are highly predictive of cell-type-specific patterns of gene expression and are therefore highly informative of cellular behavior. One such study applying epigenetic enhancer profiling to the study of cancer has revealed unprecedented insight into the molecular alterations that drive tumor formation. In the proposed studies, this approach will be applied to investigate epigenetic alterations driving the process of metastasis in the most common primary tumor of bone, osteosarcoma. This is a highly aggressive solid tumor that commonly affects adolescents, often resulting in death from metastatic progression to the lung. Unfortunately, long-term outcomes for these patients have not improved for over 30 years. Through application of this epigenetic approach, this project seeks to gain insight into the molecular underpinnings of osteosarcoma metastasis with the goal of identifying metastatic drivers that may serve as suitable therapeutic targets as well as molecular signatures predictive of metastatic risk in osteosarcoma patients. Successful completion of these studies not only offer the potential to improve outcomes for osteosarcoma patients, but also to gain insight into the process of metastasis, in general, that may inform the study of other types of cancer.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Metastatic progression is the leading cause of cancer-related deaths worldwide. Indeed, >90% of cancer deaths result from metastasis, not the primary tumor. Osteosarcoma patients are no exception. Despite the development of numerous treatment modalities targeting the primary tumor, 40% of osteosarcoma patients ultimately succumb to metastatic progression. A major limitation in the development of targeted anti-metastatic therapies in osteosarcoma and other types of cancer is a lack of understanding of the biological drivers of this process. This study seeks to apply recent advances in the understanding of epigenomic regulation of cellular function to the study of tumor metastasis in osteosarcoma. Successful completion of the proposed studies offer the potential for development of targeted anti-metastatic therapies and prognostic biomarkers for osteosarcoma patients and may also provide insights to the molecular underpinnings of metastasis that will inform the study and treatment of other types of cancer. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Distant metastases cause >90% of cancer-related mortality1. Patients suffering from osteosarcoma, where the typical route of spread is from bone to lung, are no exception. Despite the development of numerous treatment modalities targeting the primary tumor, 40% of patients still die from metastatic progression2. There is therefore a pressing clinical need to determine the factors responsible for lung metastasis in osteosarcoma to facilitate development of novel anti-metastatic therapies and prognostic biomarkers. Gene enhancer activity is a primary determinant of cellular identity and behavior3-5. The Scacheri lab recently showed that by mapping locus-specific losses and gains of enhancer-histone marks in cancer cells relative to normal cells, one can pinpoint genes commonly dysregulated in cancer that define the malignant phenotype (Science 2012). These regions are termed Variant Enhancer Loci, or VELs. The approach of VEL mapping identifies signature cancer genes that are more reproducibly dysregulated in cancer tissues than gene signatures derived from the methylome or transcriptome alone6. In the current studies, I show that a similar VEL mapping strategy may facilitate identification of genes that underlie the metastatic phenotype in human osteosarcoma. As proof of principle, I obtained a cohort of highly lung-metastatic cell lines derived from non-metastatic human osteosarcoma cell lines through sequential rounds of metastatic selection in mice from the Khanna lab at NCI. Despite their strikingly different behaviors, these metastatic and non-metastatic cell line pairs are virtually identical at the level of the in vitro transcriptome and in their mutational landscapes. However, upon applying the strategy of VEL mapping to one cell line pair, I detected epigenetic differences at thousands of enhancer elements. Enhancers gained in the metastatic cells, or "Gained Met VELs", were predicted to regulate multiple genes that normally function in early bone development (BMP4, SOX9, TWIST1,), and Lost Met VELs were linked to genes that inhibit cell motility (IGFBP3, SMAD7, NF2). I then quantified expression of the VEL genes in metastatic cells growing within the lung microenvironment using an ex vivo mouse model of pulmonary metastasis (PuMA) developed in the Khanna lab7. Remarkably, the metastatic cells showed transcriptional activation of the bone development program associated with the Gained Met VELs, and repression of the inhibitory cell motility program associated with the Lost Met VELs as they grew within the lung microenvironment. This was an exciting finding because it suggests that metastatic competence is encoded in the epigenome at the level of the gene enhancer elements. These data led me to hypothesize that an OS cell's metastatic success results from dynamic changes in gene expression within the lung microenvironment, driven by distinct alterations of the enhancer epigenome, i.e. Metastatic Variant Enhancer Loci. This hypothesis will be tested through 2 Aims (Figure 1). Aim 1: Test the commonality and functional relevance of Met VEL genes and pathways dysregulated in metastatic osteosarcoma. The described Met VEL mapping strategy will be expanded to 5 metastatic/non- metastatic cell line pairs, using ChIP-seq analysis of gene enhancer elements (H3K4Me). Similarly to above, expression of Met VEL-associated genes will be quantified within the lung microenvironment. These gene sets will also be interrogated to identify pathways commonly dysregulated across multiple lines. Following identification, expression levels of carefully selected metastatic driver and suppressor genes will be modulated in metastatic cells by shRNA knockdown or overexpression to confirm their function. Aim 2: Test whether epigenetically dysregulated genes and pathways identified in metastatic cell line models are altered in human patient tumor specimens. Through a number of established collaborations, we have unique access to transcriptome data from >200 osteosarcoma tumors, including both primary and metastatic tumors and a subset of patient-matched primary and metastatic tumor pairs. We will utilize this rich data resource to test whether Met VEL-defined metastatic drivers and suppressors may be used as therapeutic targets and/or biomarkers of metastatic risk in pediatric osteosarcoma patients Figure 1: Aims overview. Using Metastatic Variant Enhancer Loci (Met VELs) to identify metastasis genes in osteosarcoma.